Effect of inflammation on JAK2 mutant evolution in the hematopoietic system: mathematical models and experiments

PROJECT SUMMARY/ABSTRACT
Myeloproliferative neoplasm (MPN) is a hematologic malignancy characterized by the clonal outgrowth of
hematopoietic cells with a somatically acquired mutation most commonly in JAK2 (JAK2V617F), which leads to
excessive production of myeloid lineage cells. Patients with early stage MPN can spontaneously progress to
myelofibrosis, a more aggressive stage of the disease with an average survival rate of two years. Moreover,
MPN patients have a significant risk of developing acute myeloid leukemia (AML). The traditional approach to
therapy in MPN is simply to reduce the risk of blood clots with aspirin, manage symptoms, and observe for
progression of the disease. Therapeutic intervention is focused on patients with late stage disease, mostly due
to the lack of currently available therapies that halt progression. There is thus a need for interventions that impact
disease progression in MPN. Preliminary work by the laboratory of Dr. Fleischman, in collaboration with
mathematical modelers Komarova and Wodarz, has shown that inflammation can accelerate the growth rate of
JAK2V617F mutant cells relative to JAK2WT cells, and that this can potentially have a variety of consequences for
the evolution of mutant cells at homeostasis. This suggests the possibility of a new treatment modality for early
stage MPN, in which the evolutionary fate of the JAK2V617F mutants is altered and disease progression is delayed
or halted. The overall goal of this proposal is to investigate how this can be achieved. In Aim 1, experiments are
proposed that document the dynamics of JAK2WT and JAK2V617F mutant cells in isolation with and without
inflammation for the purposes of model construction and parameterization. We will also interrogate the
intracellular mechanisms responsible for the differential response of JAK2V617F mutants to inflammation. In Aim
2 we will perform experiments in which JAK2WT and JAK2V617F mutant cells are combined in mouse models with
and without inflammation. This will quantify how the number of mutants influence the kinetic parameters of wild-
type cells, which is important because we know that mutants themselves can increase inflammation and hence
alter the dynamics. In Aim 3 we will measure how a panel of existing drugs impact the kinetic parameters of cells
and use our model to predict combinations and dosing schedules that will lead to diminution of the mutant cells.
Many treatment scenarios (in sequence and in combination) will be explored, and the most promising therapeutic
approaches predicted by the model will be tested experimentally. This can identify better and currently unknown
ways in which to utilize existing drugs. On a more exploratory level, the validated mathematical model can
suggest which parameter(s) to target in which ways to make treatment more efficient than can be currently done.
This information would facilitate development of future treatments and guide drug discovery and could be
translated into a future clinical trial.

Public health relevance
PROJECT NARRATIVE Myeloproliferative neoplasm (MPN) is a hematologic malignancy driven by a somatically acquired mutation most commonly in JAK2 (JAK2V617F), which currently lacks effective therapies for early stage patients, thus necessitating the development of novel treatment modalities. Preliminary clinical and experimental work has identified inflammation as an important factor that influences the relative growth rate of mutant cells, and preliminary collaborative mathematical modeling work indicates that this can potentially have a variety of consequences for the evolution of mutant cells at homeostasis. Novel computational methods, in combination with experimentation, are used to identify mechanisms of JAK2V617F mutant selection, to predict the evolutionary trajectories of JAK2V617F mutant cells under various inflammatory conditions, and to identify and test therapeutic targets to steer cellular evolution away from disease.